ISEH 51st Annual Scientific Meeting

The International Society for Experimental Hematology (ISEH) will be holding its 51st Annual
Scientific Meeting September 1- 4, 2022 at the Edinburgh International Convention Centre in
Edinburgh, Scotland, UK. Through this request, ISEH is seeking support for young investigator
attendance and participation in the ISEH 2022 Scientific Meeting.
The ISEH annual meeting continues to be a one-of-a-kind venue offering top science from
around the world and unique networking opportunities for scientists at every career stage. ISEH
has a strong history of engaging trainees and young investigators in both the society and the
annual scientific meeting, and we plan to continue to innovate on this tradition in 2022.
Our New Investigators Committee and our newly created Junior PI Committee continue to guide
the development of activities targeted to junior (new) investigators. ISEH will host activities
specifically geared towards junior investigators at our meeting in 2022, including a pre-meeting
workshop, career development sessions for PhD and Postdocs and another for Junior Faculty,
technology session, meet-the-experts mixer, Junior Faculty grant writing workshop, featured
poster presentations and oral presentations. ISEH also provides opportunities for young
investigators and students who have submitted strong research to apply for travel grants, which
provide support for individuals who may have less funding available to attend such a meeting.
These travel grants and sessions are integral to ISEH’s meeting.
In addition to the young investigator focused sessions, the Scientific Program Committee takes
pride in developing an outstanding lineup of speakers for all meeting attendees on topics such
as tracking hematopoiesis, developmental hematopoiesis, epigenetic regulation, understanding
fate decisions, and HSC biology. ISEH meetings feature some of the best unpublished research
from around the world, including talks from invited speakers as well as oral and poster
presentations.

Public health relevance
The International Society for Experimental Hematology’s (ISEH) Annual Scientific Meeting is an important forum for senior scientists, young investigators, and trainees from around the world to discuss and exchange original, unpublished research advancing the areas of hematology, hematologic disorders, stem cell biology, cell therapy and immuno-oncology. ISEH is committed to providing an inclusive, respectful, safe, and welcoming environment, to promote the sharing, discussion and exchange of basic, clinical and translational findings. The ISEH meeting is distinctly different from some of the larger, broader meetings on these topics, because it provides unparalleled opportunities for meaningful interaction, scientific debate, and mentorship for scientists around the world. The critical networking enabled at ISEH’s meeting advances the next generation of scientific leaders in experimental hematology, resulting in the translation of discoveries into drug development and critical therapies.